Synthesis and Exploration of Highly Fluorescent Thiazolothiazole Molecular Sensors for Probing Membrane Potential Dynamics

PROJECT SUMMARY
The long-term goal of this project is to understand how highly fluorescent thiazolothiazole molecular sensors are
impacted by changing electric fields in cellular membranes. Tracking these changes offers the potential to gain
a deep understanding of complex and rapidly changing cellular physiology. Fluorescent, small molecule voltage
sensitive dyes (VSDs) have greatly impacted this field, however, there is still a great need to develop new dyes
with enhanced long wavelength emission for imaging in thick tissues, improved photostability for long-term
imaging, and improved cell membrane voltage sensitivity. In this project, we propose the continued exploration
of unique and highly fluorescent thiazolo[5,4-d] thiazole molecular fluorophores. TTz dyes are the next
generation of imaging tools because they exhibit high photochemical stability, are easy to prepare/modify, show
fast response times, good cell membrane localization, negligible cytotoxicity, and are sensitive to cellular
membrane potential. We recently developed a highly improved method to synthetically access asymmetric TTz
dyes for cell membrane applications. In addition, we are leveraging new insights into the sensing mechanism of
the TTz dyes to design molecular probes with even greater cell membrane potential sensitivity. We will conduct
spectroscopic and electrochemical characterizations to understand the role of molecular structure on the cell
membrane localization and voltage sensing. We will evaluate the cell membrane voltage sensing performance
of the dyes, which will provide important feedback for further tuning of their photophysical properties.

Public health relevance
PROJECT NARRATIVE Cell membrane potentials can be optically detected using new fluorescent dyes called “TTzs.” The low-cost dyes have bright fluorescence and are designed to detect cell membrane electrical signals in real time. The proposed research will develop new TTz dyes that leverage newly discovered fluorescence mechanisms to improve their voltage sensing performance and versatility.